TASK ORDER B03: EVALUATION OF ANTIVIRAL DRUG CANDIDATES AGAINST MPOX IN NHPS

This contract provides for the development of new and refinement of non-human primate models of infectious diseases and may include evaluation of candidate countermeasures.